Low Vision Assessments in Virtual Reality (LVAVR)

Project Summary/Abstract
In recent years, patient centered outcomes (PCOs) have rapidly gained a prominent role in clinical trials
throughout medicine, and ophthalmology is following this trend. There is, however, little uniformity in the
measures currently in use, even though the FDA has been emphasizing the importance of standardizing
clinical trial outcomes for over a decade. Several visual functioning questionnaires (VFQs) and standardized
reading tests are available, calibrated in multiple languages. However, for other visually guided (instrumental)
activities of daily living – (I)ADLs –, whether related to information gathering, visually guided action, wayfinding,
or detail discrimination (the 4 visual domains generally recognized in low vision rehabilitation), there currently
are no standardized performance assessments. One reason for this is the difficulty to create uniform real-
world visual activities: They depend on available tools, test conditions, and other factors that may be difficult to
reproduce across sites, let alone in countries with different customs, tools/utensils, measures, etc. The current
proposal fills this void by developing and calibrating a broad set of visual performance measures in virtual
reality (VR). It is built on 5 years of experience our team has gained through the development of 3 reliable sets
of activities in VR for a population with ultra-low vision, i.e., VA”20/1600. In this proposal, we address the
much broader low vision population with 20/00” VA”20/0 or restricted peripheral fields (<20° diameter).
We start out with an inventory of relevant (I)ADLs, calibrated in the form of a 125-item VFQ. From these
items we select activities for the functional assessment, in all 4 visual domains. All activities will be created in
virtual reality (VR), and participants will perform these while wearing a wide-screen VR headset with built-in
hand and eye tracking. A subset of the activities will also be created as real-world tests to allow comparison of
the two test modalities. Each activity will comprise 2 or 5 steps that are pass/fail scored; scores are analyzed
using the method of successive dichotomizations (MSD). Effects of auditory and haptic complements to the
visual information in VR will also be examined. In Aim 1, we will develop and calibrate the VFQ, administered
to 300 low vision respondents. In Aim 2, 20 activities in real-world and VR modalities will be compared in 150
participants across 3 participating centers. In Aim 3, 60 activities in VR will be calibrated in 225 participants
across the 3 centers, and in Aim 4, the contribution(s) of auditory and/or haptic feedback will be studied, also in
225 participants.
Psychometric analyses will yield calibrated item (difficulty) measures for the VFQ and the activities in VR.
The Low Vision Assessment in Virtual Reality (LVAVR) will consist of up to 60 activities, the VFQ of up to 125
items. Both instruments will be made available for clinical and research use.

Public health relevance
Project Narrative The overall goal of this proposal is to create and calibrate visual activities in virtual reality that will measure how well people with poor eyesight can use their vision, by estimating the difficulty of each activity in a large group of individuals with different levels of vision loss. They will perform these activities while wearing a head- mounted display and using vision alone, but also when enriching the activity with sound and/or touch. We will choose the activities on the basis of patients’ ratings of what is important and difficult for them due to vision loss, and compare participants’ performance of some of the activities in virtual reality the real world.